Mitochondrial Biochemistry: From Mechanisms to Disease

Project Summary/Abstract
Mitochondria are the major source of cellular energy and are also one of the major sites of defects leading to
age-related disorders. In spite of the obvious importance, roughly 1/3 of the proteins found there have no
know function. One major goal of the Rutter laboratory is to define the functions of a subset of these proteins,
particularly those that are highly evolutionarily conserved across eukaryotic species. We have begun this
process and have defined the molecular functions of ten mitochondrial protein families. These have included
important factors for OXPHOS complex assembly, mitochondrial quality control, metabolic regulation and
others. These discoveries have enabled our laboratory and many others to develop new understanding of
normal human physiology and disease pathophysiology, including the discovery of two new human disease
genes. The proposed future activities are a combination of continuing our efforts to define the functions of
previously unstudied mitochondrial proteins and leveraging our previous discoveries toward a better
understanding of mitochondrial biology and its physiological manifestations.

Public health relevance
Project Narrative Mitochondria are the major source of cellular energy. They also play a disproportionately large role in the pathophysiology of age-related human disease. The goal of this program of study is to define previously unknown aspects of mitochondrial biochemistry and understand how this affects human physiology.